Temporal Pattern Perception Mechanisms for Acoustic Communication

Project Summary/Abstract:
Processing temporally patterned acoustic communication signals is an important function of the auditory system
and crucial to human speech and language. Understanding the neurobiological mechanisms that support these
basic communication abilities holds promise for improving treatments for learning disabilities and communication
disorders, including auditory processing disorder, dyslexia, and specific language impairment. While non-
invasive studies in humans reveal brain loci of some language-related processes, the neurobiological
mechanisms that support temporal pattern processing of communication signals remain poorly understood.
Predictive coding, a general computational framework in which incoming sensory signals are compared to
internal models, provides a potential mechanism for temporal pattern perception in the context of communication.
This proposal investigates neurobiological mechanisms of predictive coding, by leveraging the songbird model,
which permits invasive neuroscience methods, access to acoustically complex learned vocal communication
signals, and natural communication behaviors. One sensory driven communicative behavior guided by internal
models is recognition, i.e. matching an internal model to the sensory input corresponding to, for example, a word
or face. In Aim 1, we test the cellular- and neural population-level predictions of predictive coding in the context
of vocal recognition, examining how predictive errors generated in reference to learned internal models from the
songs of individual birds, can guide recognition behavior. We combine state-of-the-art machine learning methods
with large-scale multi-electrode electrophysiology, to test explicit models for natural stimulus representation,
prediction, and error coding in single neurons and neural populations in secondary auditory cortical regions in
awake birds during individual vocal recognition. A second way that internal models shape communicative
behavior is in sensory feedback during vocal production. As we speak (or as birds sing) the auditory system
continuously monitors the temporal structure of the sounds we produce, ensuring that the syllables, words, and
phrases that emerge match our intentions. In Aims 2 and 3, we use the predictive coding framework to investigate
sensory feedback and vocal-motor intention. We examine the coordination of neural population activity between
sensory and motor regions, and identify neural dynamics tied uniquely to vocal-motor intentions in a secondary
auditory region. We then causally manipulate this internal sensory-motor model, using both a behavioral
manipulation to distort the sensory-feedback signal, and using optogenetics to directly modulate the
hypothesized internal model that arises in motor control regions. Results of the proposed studies will yield
understanding of neurobiological substrates foundational to communication behaviors, and a general framework
within which more complex, uniquely human processes, can be proposed and tested.

Public health relevance
Project Narrative: Normal speech comprehension and communication are rooted in basic auditory cognitive processes. Deficits in these processes accompany severe communication disorders (e.g. auditory processing disorder, dyslexia, specific language impairment, autism), and their abnormal function can compound the negative impacts of hearing impairments. The proposed project investigates the neuronal mechanisms of auditory temporal pattern processing using natural communication signals, with the ultimate goal of understanding the neurobiological basis of language-relevant abilities and improving treatment of communication processing disorders.